Regulatory Affairs Support

To provide scientific, regulatory, technical, project management, and administrative assistance for a broad spectrum of regulatory activities in support of NIAID clinical research activities.